Trimming the fat with small proteins: Micropeptides in adipogenesis

Project Summary/Abstract
Obesity is an ongoing epidemic, with more than two-thirds of adults in the US considered to be overweight or
obese. Treatment options for these patients, including all FDA approved anti-obesity drugs, are ineffective for
long term weight loss. The lack of effective treatments for obesity signals a gap in knowledge. The white adipose
tissue is responsible for maintaining energy storage and release to maintain fuel homeostasis in the body.
Disruption of white adipocyte function due to excess energy intake is a major contributor to the pathogenesis of
obesity, resulting in insulin resistance, type 2 diabetes, and other metabolic diseases. Recent advancements in
gene sequencing and mass spectrometry technology have allowed scientists to identify small Open Reading
Frames (smORFs), which encodes functional microproteins that have a wide range of biological roles. The
Saghatelian laboratory has pioneered a suite of multi-omic platforms that integrate proteomics, ribosome profiling
(Ribo-Seq), and RNA sequencing to accurately annotate smORFs of less than 150 codons. By performing Ribo-
Seq on models of murine adipocytes, the applicant has identified 1721 novel smORFs in the mouse genome.
The great majority of these smORFs are uncharacterized. This major goal in this proposal is to address this
knowledge gap by characterizing novel adipocyte smORFs that are involved in adipogenesis (Aim 1) and insulin
signaling (Aim 2). Using a CRISPR/Cas9 library screen specifically targeting the 1721 novel smORFs, the
applicant has already identified ~20 smORFs that specifically inhibit adipogenesis. Subaim 1.1 will validate
these findings through generation of smORF knockout 3T3-L1 preadipocytes to assess how specific smORFs
affect adipocyte differentiation, followed by rescue experiments through overexpressing smORFs in knockout
cells. In Subaim 1.2, the applicant will dive deep into the function of a specific microprotein identified in Subaim
1.1 by characterizing its cellular location and microprotein-protein interaction. In Aim 2, the applicant will exploit
the genomic and physiology data from the Diversity Outbred (DO) mice to identify smORFs that correlates with
physiological changes, such as body weight, blood glucose, and triglycerides. The applicant will determine
whether knocking out the smORFs identified from this analysis in 3T3-L1 cells will affect insulin signaling and
glucose uptake under normal conditions and in in vitro models of insulin resistance. Completion of these studies
will reveal how smORF and microproteins regulate adipocyte differentiation and insulin signaling.

Public health relevance
Project Narrative There exists a knowledge gap in obesity and adipocyte biology, as there are still no effective anti-obesity drugs or treatments. Recent identification of previously unannotated microproteins in human and mouse genomes has been made possible by breakthroughs in genomic and proteomic technologies. By applying these new methods on adipocytes, this study will characterize adipocyte microproteins that affect adipogenesis and insulin signaling.